Saliva based protein markers for predicting the risk of cognitive decline and dementia in older adults.

Project Summary
As our population ages, the prevalence of aging-related disorders such as cognitive decline, Alzheimer’s
disease (AD), and its related dementia (ADRD) is increasing, with poor or no prognosis, prevention, and
treatments. This, in turn, burdens families, society, and our healthcare system. Although, several recent
advances have led to the development of prognostic markers of ADRD including advanced imaging like MRI,
PET, and measurements of amyloid-β (Aβ) and tau proteins in cerebrospinal fluid (CSF) and blood; but their
uses are impeded due to cost, invasiveness, and required frequency of measurements, with limitations in
sensitivity and accuracy. Thus, developing new, non-invasive, sensitive, and easy to frequently measure with
increased accuracy biomarkers for predicting the risk of early onset of cognitive decline and ADRD progression
is direly needed. Saliva is an attractive reservoir of biomarkers that can noninvasively and inexpensively be
collected with unlimited frequency. We hypothesize that saliva protein markers can differentiate mild cognitive
impairment (MCI) and dementia from cognitively healthy individuals. We also posit that these saliva protein
markers can predict the risk of MCI and dementia, and the inclusion of oral microbiome and systemic
inflammatory markers will strengthen the discriminatory and predictive power. Our hypothesis is based on
strong fundamental knowledge and preliminary data. The fact that the oral cavity’s mucosal and lymphatic
systems are connected to the brain circulations and are in physical proximity, which allows the bidirectional
exchange of molecules like proteins and peptides, between oral and brain systems. Abnormalities in the oral
microbiome and systemic inflammation are linked to the risk of cognitive decline and ADRD, but these
conclusions are drawn from small, cross-sectional, observational, and non-prospective risk prediction studies.
Here, using our ongoing large clinical cohort- Microbiome in aging Gut and Brain (MiaGB) consortium study,
we plan to globally analyze proteomics and oral microbiome in saliva along with markers of inflammation in
plasma of 60 cognitively normal, 60 MCI, and 40 dementia participants in both cross-sectional and prospective
follow-up studies to test our hypotheses. We plan two specific aims. In Aim 1 we will determine if unique
proteomic signatures differentiate subjects with MCI and dementia from cognitively healthy controls and if the
addition of microbiome and inflammatory markers boosts the distinction; and in Aim 2, we will determine if
saliva-based protein markers predict the risk of MCI and dementia progression and whether the inclusion of
microbiome and inflammation strengthens the prediction in older adults. Building on an already ongoing large
study and supported by compelling preliminary data and complementary expert team and interlinked aims, our
study is expected to establish proof of concept that saliva-based biomarkers will diagnose and predict the risk
of cognitive decline and dementia progression, which is increasingly common, costly, and debilitating public
health problems in older adults, while it is well aligned with the goals of PAR-22-094.

Public health relevance
Project Narrative Many aspects of age-related cognitive decline, Alzheimer’s disease (AD), and its related dementia (ADRD) start several years before the full symptoms are diagnosed, however, markers to early predict them are limited. Here, we aim to establish saliva-based protein, microbiome, and inflammatory biomarkers diagnosing and predicting the progression of age-related cognitive decline and ADRD- debilitating, costly, and non-curable public health problems in older adults. The outcomes of this study will establish proof-of-concept that can be validated in large clinical studies, fulfilling the R21 application objective and perfectly aligning with the goals of NIA’s PAR-22-094.